LARGE-SCALE PREPARATION OF ANTI-AIDS DRUGS

The major objectives of this project is the preparation of known chemicals and bulk drugs which are needed by the Programs for clinical use. The compounds selected for preparation are not readily available in the quality or quantities required from the original supplier or on the open market. This project provides the means to obtain nearly and type of chemical compound and the ability to provide large quantities of very high purity drugs. Assignments of materials for preparation will originate with the Pharmaceutical Resources Branch. NCI and will involve a wide variety of chemical structures. Many of the preparations will involve multi-step sequences and all materials prepared will be fully characterized.